Implementation and Evaluation of Patient Priorities Care-North Carolina for Older Adults with Multiple Chronic Conditions

Project Summary/Abstract
The long-term goal of this research is to re-engineer clinical decision-making for older adults with multiple
chronic conditions (MCC) to center within the health priorities of patients. The overall objective of this Research
Project Grant Program (R01) study is to implement and evaluate a Patient priorities care (PPC) intervention in
primary care practices in North Carolina (NC) using a hybrid effectiveness-implementation design. Guided by
the Minimally Disruptive Medicine model, our central hypothesis is that clinical decision-making guided by
patients' priorities will result in less burdensome care for patients and their families, increase patient goal
setting, facilitate patient-provider shared decision-making, and improve patient quality of life and satisfaction
with care. As the prevalence, costs, and treatment burden of MCC continue to rise, new approaches to care
are urgently needed in this growing population. Findings from this study will inform practical approaches for
aligning clinical decision-making in older adults with MCC with their health priorities. This project is highly
relevant to priorities of the National Institute on Aging (NIA) which call for research to develop and evaluate
health care models and approaches aligned with patient values, preferences, and goals in older adults with
MCC.

Public health relevance
PROJECT NARRATIVE Health care for individuals, particularly older adults, with multiple chronic conditions (MCC) is complex, burdensome, and of unclear benefit. The disease-based clinical performance metrics and outcomes on which clinicians' decision-making are based are often not the ones that matter most to patients with MCC. This project aims to implement and evaluate Patient Priorities Care- an innovative 3-step process designed to align care and clinical decision-making with the health priorities (health outcome goals and health care preferences) of older adults with MCC, in 8 primary care practices in North Carolina.